NIA AD/ADRD Health Care Systems Research Collaboratory

PROJECT SUMMARY
Over five million Americans have Alzheimer's disease (AD) or an AD-related dementia (AD/ADRD). These high-
need, high-cost patients are vulnerable to receiving poor quality, uncoordinated care, ultimately leading to
adverse health outcomes, poor quality of life, and misuse of resources. As recently concluded by the federally-
funded Research Summit on Dementia Care, improving the care of PWD and their CGs is an urgent public health
challenge that must be met and informed by high quality evidence. While prior research has elucidated
opportunities to improve the care of PWD and their CGs, the adoption of promising interventions has been
stymied by the lack of research evaluating their effectiveness when implemented under “real-world” conditions.
Pragmatic clinical trials embedded (ePCTs) in healthcare systems (HCS) have the potential to accelerate the
translation of evidence-based interventions into clinical practice. Since its inception in 2012, the NIH Common
Fund HCS Research Collaboratory has made pivotal contributions towards advancing the conduct of ePCTs.
However, as concluded in a 2017 NIA-sponsored conference, ePCTs conducted with PWD and their CGs have
unique considerations that merit specific focus. Thus, the overarching objective of this proposal is to build on the
model of the NIH Collaboratory to establish the National Institute on Aging (NIA) AD/ADRD Research
Collaboratory, co-led by the multiple principal investigators (MPIs), Drs. Vince Mor (Brown University) and Susan
Mitchell (Hebrew SeniorLife (HSL)) and co-administered by their respective institutions. The Aims are: 1. To
establish the infrastructure of the AD/ADRD Collaboratory, 2. To develop and disseminate guidelines for the
conduct of all aspects of ePCTs among PWD and their CGs in partnership with HCS, 3. Enhance research
development and investigator capacity to conduct ePCTs in PWD and their CGs within HCS, and 4. To
disseminate knowledge and best practices to engage stakeholders in this research. Accomplished investigators
from across the nation will lead the following Working Group Cores: 1. Technical and Data (B), J. Bynum, MD,
MPH; 2. Regulation and Ethics (C), J. Karlawish, MD; 3. Design and Statistics (D), H. Allore, PhD; 4. Pilot Studies
(E), A. Brody, PhD, RN; 5. Patient and CG Reported Outcomes (F), L. Hanson, MD, MPH; 6. Dissemination and
Implementation (G), L. Gitlin, PhD/J. Gaugler, PhD; 7. HCS (H): E. Larson, MD, MPH, and Training (I): C.
Callahan MD/A. Torke MD. An Administration Core (A) will integrate all critical functions across the Collaboratory.
IMPACT: There is an urgent need to improve care provided by HCS for PWD and their CGs. ePCTs conducted
are ideally-suited to test the effectiveness of interventions aimed at improving their health outcomes but require
specific expertise, methodology, data sources, and industry partnerships. The knowledge, investigative
experience, collaborations, and evidence generated by an AD/ADRD Collaboratory has the potential to transform
the delivery, quality, and outcomes of care for Americans from all backgrounds with AD/ADRD and their CGs.

Public health relevance
NARRATIVE There is an urgent need to improve care provided to patients with dementia (PWD) and their caregivers by health care systems (HCS). Few evidence based non-pharmacologic interventions have been embedded in HCS and tested for effectiveness. Pragmatic clinical trials conducted within HCS are ideally-suited to test the effectiveness of such interventions but they require specific expertise, methods, data sources, and industry partnerships. The knowledge, investigative experience, collaborations, and evidence generated by the proposed National Institute on Aging Alzheimer's disease (AD)/AD-related dementia (AD/ADRD) Collaboratory has the potential to transform the delivery, quality, and outcomes of care for Americans from all backgrounds suffering with AD/ADRD.